Developing a baboon model for uterine fibroids

By age 50, most women will have had uterine leiomyomas (fibroids) with a lifetime cumulative incidence of ~70%
for White women and >80% for Black women. Approximately 25% of women with fibroids experience symptoms
severe enough to cause them to seek clinical care. Although they are a significant healthcare burden for many
individuals, the etiology and pathophysiology of fibroids is poorly understood. Fibroids are the most common
reason for hysterectomy in the US, yet fibroid incidence and symptomatology are poorly understood. The current
gap in knowledge about the etiology and pathophysiology of the disease has contributed to the lack of safe and
effective long-term strategies for women with the disease. Very little is known about the underlying mechanisms
that lead to fibroid development. One of the main reasons that fibroid biology is poorly understood is the lack of
a good model system to study the disease. Perhaps, the best model available is a kidney capsule xenograft
model in immunocompromised mice but their translational potential is not clear. Several other animal models,
including some genetically modified mice, have been proposed for fibroid research, but each has significant
limitations that prevent their widespread use in the laboratory. Our goal is to develop a standardized and reliable
orthotopic baboon model for uterine fibroid research, which we propose to do in two phases. There are several
reasons for choosing the baboon for this purpose. The baboon is not endangered, has been used by many
laboratories to study reproductive biology because of the species phylogenetic similarity to humans and most
importantly, baboons develop spontaneous uterine fibroids, themselves, a trait shared by all primates examined.
In Phase 1 of the project, we propose to develop stable, immortalized, and clonal baboon myometrial cell lines
that mimic uterine fibroid cells from human as closely as possible with the following Aims: establish baboon
immortalized myometrial cell lines that correspond to the most common genetic subtypes observed in human
fibroids and perform in vitro and in vivo assays to select the most promising cell lines for transplantation into
baboon hosts. Successful completion of these aims will allow us to apply for R01 funding to perform Phase 2 of
the project, the orthotopic allograft assays baboons with our collaborators.

Public health relevance
Uterine fibroids are common noncancerous tumors that can cause women to have severe bleeding, pelvic pressure and pain, urinary dysfunction, and adverse pregnancy outcomes. How fibroids develop or how they can be treated without resorting to hysterectomy is not well understood, in large part because it is difficult to study in humans. Our goal in this proposal is to begin developing a better model system to study fibroid biology and test new therapies.